2025 ISMRM Workshop on Perfusion MRI: Found in Translation

Project Summary/Abstract
We propose to hold an International Society for Magnetic Resonance in Medicine (ISMRM) Workshop
entitled "Perfusion MRI: Found in Translation" in Pamplona, Navarra, Spain. Perfusion MRI provides important
diagnostic biomarkers in many diseases throughout the body, beyond those available from standard anatomic
MRI. The significance of Perfusion MRI has been extended to all specialties of medicine. The purpose of the
proposed ISMRM Perfusion MRI Workshop is to bring together scientists and clinicians interested in technical
research and application-oriented innovations in perfusion MRI.
The Workshop has three aims: Aim 1 is to organize an interdisciplinary international workshop
highlighting the opportunities and challenges of perfusion MRI; Aim 2 is to discuss the key questions and gaps
in the Perfusion MRI field to guide future research and clinical applications; Aim 3 is to promote harmonization
of imaging protocols and disseminate existing tools for the analysis of perfusion data and training resources
related to perfusion imaging techniques.
This workshop will be of great interest to the clinical community, such as neurology, psychiatry, oncology,
cardiology, nephrology, pulmonology, hematology, and orthopedics. The organizing committee consists of a
diverse group of scientists and clinicians with inclusion of women and underrepresented minorities as well as a
mixture of junior and senior investigators. A diverse panel of world renowned scientists and clinicians will present
their research in methodologies and applications of perfusion MRI. The Workshop will be CME accredited. The
Workshop will employ several novel approaches. Scientific presentations will be combined with new socializing
and networking methods to provide ample opportunities of discussion, collaboration, and brainstorming.
To maximize the impact of the Workshop on the scientific community and to move the perfusion MRI field
forward, we will set concrete goals. Therefore, the 2025 Perfusion MRI Workshop will be a timely event to unify
and further publicize recent efforts in perfusion MRI, and to disseminate open source tools for perfusion image
processing and analysis. By holding panel discussions with industry vendors, we expect to set much-needed
standards for the implementation of perfusion protocols across platforms.

Public health relevance
Project Narrative We propose to hold an International Society for Magnetic Resonance in Medicine (ISMRM) Workshop entitled “Perfusion MRI: Found in Translation", in March 2025 in Pamplona, Navarra, Spain. Perfusion MRI provides important diagnostic biomarkers in many diseases throughout the body. The proposed Workshop will set a milestone for broader applications of perfusion MRI in clinical disciplines such as neurology, psychiatry, oncology, cardiology, nephrology, pulmonology, hematology, and orthopedics.